Global Health Research and Training in Cardiovascular Disease

ABSTRACT: The goals of this K24 proposal are to train clinical investigators in the conduct of patient-oriented
cardiovascular disease (CVD) research primarily in Haiti, with a new project in Tanzania and to conduct a new
study on environmental lead exposure and CVD risk factors in Haiti (Aim 1). The training also leverages four
currently funded CVD research projects in Haiti (Aims 2-5), and a funded CVD research project in Tanzania
(Aim 6). United States trainees will spend ~50-60% of their time at international research sites in Haiti and
Tanzania, which have onsite Weill Cornell faculty, long-standing international collaborators, and outstanding
environments for research training. The common theme of the projects is patient-oriented CVD research in the
areas of clinical epidemiology, clinical trials, CVD-infectious diseases, and implementation science. The
projects include:
1. Environmental lead exposure and CVD risk factors in Haiti
2. Clinical epidemiology of CVD risk factors, diseases, and poverty-related social determinants in Haiti
3. Randomized clinical trial of early hypertension treatment among persons living with HIV
4. COVID-19 and cardiac dysfunction
5. Implementation of hypertensive screening and management
6. Heart failure in Tanzania
The focus of research training will be on postdoctoral clinical investigators who have completed their advanced
degree training. Dr. McNairy has an impeccable history of excellence in research mentorship and serves in
leadership roles in the Weill Cornell Global Health Research Fellowship and the Weill Cornell Women in Global
Health Research Initiative. Trainees will be mentored by Dr. McNairy and will participate in research projects in
Haiti (Aims 1-5) and Tanzania (Aim 6). These six projects have both clinical and laboratory aspects and offer
trainees a broad research experience. Trainees learn through the conduct of their mentored research project
and the opportunity to interact with colleagues working on studies other than their own. The K24 award will
allow Dr. McNairy to decrease her administrative and clinical responsibilities and commit 50% effort to CVD-
related research and mentorship of US trainees. Her long-term goal is to build a world-class CVD global health
research and training program to improve CVD-related health outcomes among the world's poorest
populations.

Public health relevance
NARRATIVE: The K24 proposal will support Dr. Margaret McNairy to train clinical investigators in the conduct of patient-oriented cardiovascular disease research in Haiti and Tanzania, and to conduct a new study on environmental lead exposure and cardiovascular disease risk factors in Haiti. United States trainees will spend ~60% of their time at international research sites in Haiti or Tanzania, which have onsite Weill Cornell faculty, long-standing international collaborators, and outstanding environments for research training. All the projects have patient-oriented research on cardiovascular disease as their focus and offer trainees a broad experience in the conduct of mentored research in the topics of cardiovascular epidemiology, clinical trials and implementation science.